PEDSnet Scholars: A Training Program for Pediatric Learning Health System Researchers

PEDSnet Scholars: A Training Program for Pediatric Learning Health System Researchers
Project Summary/Abstract
Creating learning health systems (LHSs) that improve child health will require a new generation of researchers
embedded in healthcare organizations’ clinical operations and translational research programs. Their work will
directly align with the expressed needs of patients, parents, providers, and health system leaders. The
evidence base they create will inform health-related decisions of patients and providers and will inform
decisions of system leaders focused on improving the quality and efficiency of care. They will also conduct
research on implementation of practices that reliably improve health and wellbeing in a wide range of contexts,
in order to benefit all children, and to reduce persistent disparities in child health by race, ethnicity, and socio-
economic status. Our proposed career development program leverages a broad and diverse faculty across the
participating institutions in PEDSnet (pedsnet.org), a research network in PCORnet. Our faculty has over 2
decades of experience in training child health researchers in health services and outcomes research,
implementation science, quality improvement, and informatics. The program, called PEDSnet Scholars, will
draw from an extensive and diverse pool of applicants (MD and PhD faculty) from 8 pediatric academic
medical centers. The program will be organized around an unrelenting focus on improving outcomes. Its
Leadership Team co-led the development of the AHRQ learning health system researcher competencies (see
Forrest et al, HSR, 2017), has led several post-doctoral and faculty-level health services research, quality
improvement, and patient-centered outcomes research training programs, and has an existing long-term
relationship working in PEDSnet, a national pediatric learning health system. The 49-member faculty provides
additional research, improvement, leadership, and informatics expertise. An external Program Advisory Panel
composed of national leaders in pediatric research and improvement and the PEDSnet Engagement
Committee composed of parents and clinicians will support the faculty and scholars. We will leverage these
resources to: (1) provide scholars with intensive mentorship and training in co-production of research among
patients, parents, and other stakeholders in LHSs; (2) deliver a core curriculum that builds competence in
conducting LHS research; (3) support scholar career development, including helping to create a career map
that aligns scholars’ academic success with productive research of value to patients, families, and health
systems; and, (4) create a community of junior faculty who will become leaders in their institutions and the
nation in realizing the promise of LHS research for children. The mentorship team for each Scholar will include
a local scientist, a senior health system executive, and a scientist from another PEDSnet institution. The
program will produce Scholars whose careers align with the needs of children, pediatric delivery systems, and
their communities. These individuals will provide the evidence for shared clinical decisions and effective
system-based interventions that will bring us closer to the goal of improved health for all children.

Public health relevance
PEDSnet Scholars: A Training Program for Pediatric Learning Health System Researchers Project Narrative The proposed PEDSnet Scholars training program will contribute to a new generation of investigators committed to co-producing research with health system stakeholders in order to improve child health and health system performance. The structured training and intensive mentorship they receive in research, health system leadership, improvement, and meaningful coproduction of research will make them leaders in testing innovations in healthcare delivery, biomedical science, informatics, and technology and implementing best practices. Application of these skills will directly improve health outcomes of the nation’s children and the performance of pediatric healthcare organizations.